CORE A1 - Administative

Project Summary: The purpose of administration core is to provide formal organization structure of the South Carolina Bioengineering Center of Regeneration and Formation of Tissues (SC BioCRAFT). The Administrative Core has three components: Business Management, Faculty Development, and Programmatic Development. PI Dr. Naren Vyavahare directs the Administrative Core with the assistance of Co-Directors Drs. Roger Markwald and Thomas Borg. This core will provide integrated fiscal and administrative management for all components of the program, including coordination of all meetings, management of all fiscal and personnel matters, and accountability for COBRE funds and resource. The core will also provide scientific and programmatic leadership, including implementation and review of mentoring, allocation of resources, planning, and evaluation activities. Core leadership will design and coordinate new programmatic activities to sustain and expand faculty-development activities and collaborative relationships among faculty within the SC BioCRAFT COBRE for the long term.